Understanding and Enhancing T-Cell Responses to High Risk Human Papillomaviruses-Renewal

PROJECT SUMMARY
It is estimated that human papillomavirus (HPV) is responsible for 42,700 cancers in the US each year and that
it caused more than 90% of anal and cervical cancers and about 70% of oropharyngeal, vaginal, and vulvar
cancers. The increases in incidences of HPV-associated anal and oropharyngeal cancers in the US are
notable, and cervical cancer is the fourth most common cancer among women globally. This is the second
competitive renewal of this R01, which has the long-term goal of developing therapeutic vaccines for HPV. This
is significant because currently available prophylactic vaccines are effective only for preventing HPV infections,
but not for eliminating them once they are established. The estimated lifetime probably of acquiring HPV is
91.3% for men and 84.6% for women. We developed and are testing PepCan, a therapeutic vaccine that
consists of four “current good manufacturing grade” synthetic peptides that cover the E6 protein of HPV type
16 (HPV 16), along with a Candida skin-test reagent as a novel vaccine adjuvant. Our dose-escalation single-
site Phase I clinical trial of PepCan to treat women with cervical high-grade squamous intraepithelial lesions
(HSILs) was recently completed. It demonstrated safety, a significant decrease in HPV 16 viral load, and a
significant increase in circulating T-helper type 1 cells after vaccination. A randomized (to two treatment arms),
double-blind, Phase II clinical trial is on track to complete recruitment soon. Furthermore, in a double-blind,
placebo-controlled (3:1 ratio) Phase I/II clinical trial, PepCan is being tested to reduce recurrence of squamous
cell carcinoma of head and neck in patients who reach “no evidence of disease” status after curative treatment.
The following aims will test our hypothesis that PepCan induces HPV-specific immune responses, resulting in
reduced recurrence of head and neck cancer (HNC) and increased regression of HSILs when the effector cells
(i.e., T-cells) reach the disease sites.
Aim 1: Assess efficacy and safety of our HPV therapeutic vaccine for HNC recurrence reduction
and cervical HSIL regression
Aim 2: Examine immune factors that influence PepCan response and vaccine mechanisms
Aim 3: Examine how microbiomes of gut and of disease sites (cervix and mouth) contribute to
vaccine efficacy
Results of the proposed investigations may lead to FDA approval of a therapeutic vaccine for two HPV-related
cancers and to an improved understanding of immunotherapy mechanisms.

Public health relevance
Project Narrative The human papillomavirus (HPV) therapeutic vaccine being developed is likely to become a first-line therapy for high-grade squamous intraepithelial lesions (precursors of cervical cancer). This is particularly important for women who wish to have children because the standard surgical treatments have the unintended side effect of doubling the incidence of preterm delivery. In addition, the vaccine is being tested for the ability to reduce recurrence rates of head and neck cancers, and it may be used to prevent or treat other cancers caused by HPV, including anal, penile, vaginal, and vulvar cancers.